Structural and Functional Studies of Protein Kinase C Regulation

Protein Kinases C (PKC) define a family of lipid-activated kinases that are key effectors of phosphoinositide
signaling – a major intracellular signaling pathway of eukaryotic cells. Consistent with this central activity,
dysregulation of PKC signaling is implicated in cancer progression, cardiac disease, diabetes, and Alzheimer’s
disease. Because of the fundamental role of PKC in signal transduction, the development of modulators of PKC
activity – both for therapeutic and basic research purposes – is widely recognized as one of the major challenges
in the field. Addressing these challenges requires an atomic-level description of PKC control – in particular, how
lipids and exogenous agonists regulate PKC activity. This requirement defines a major gap in understanding of
PKC regulatory mechanisms. This research proposal builds upon two key discoveries made by our laboratory.
First, an atomistic resolution of how DAG is recognized and captured in membranes by the conserved homology
1 (C1) domains of PKC that eluded the field for 30 years. Second, the discovery that novel PKC isoforms have
an unexplored lipid-sensing function that adds a novel facet to control of PKC activity. This renewal application
proposes to apply an integrated research strategy consisting of solution NMR spectroscopy, x-ray
crystallography, atomistic molecular dynamics simulations, and imaging experiments in yeast and mammalian
cells to address the following Specific Aims: (1) determine the role of phosphoinositides in PKC localization and
activation, and (2) determine the molecular basis of PKC activation by novel tool compounds and drugs that
target the C1 domains. These studies will deliver functional, structural, thermodynamic, and kinetic information
to understand the determinants of potency and isoform selectivity of exogenous PKC agonists and provide key
information regarding how PKCs execute coincidence detection of DAG and phosphoinositides. Insights into the
PKC regulatory mechanisms obtained from the proposed studies will be impactful in that these will extend the
already large problem of PKC regulation into previously unexplored areas. The atomistic information regarding
C1 interactions with exogenous ligands and regulatory lipids will be directly applicable to five other large families
of essential signaling proteins that rely on C1 domains for regulation of their DAG-dependent activities. This
knowledge will also facilitate a more efficient structure-based design of pharmacological agents that modulate
PKC activity by direct targeting of its C1 domains.

Public health relevance
Protein Kinase C (PKC) enzymes have been implicated in many human pathologies. We will uncover the molecular mechanisms that regulate the enzymatic activity of PKC. The results of the proposed studies will facilitate the development of novel ways to prevent the progression of cancer, Alzheimer’s disease, and cardiac disease.